PH1 DOSE ESCALATING STUDY OF RECOMBINANT HUMAN INTERLEUKIN 12

This is an open label, non randomized, Phase I dose escalating study of rhIL-12 administered by intraperitoneal (IP) infusion in adult male or female patients with measurable disseminated intraperitoneal cancer that is residual, recurrent or metastatic. Neither a control or placebo group will be utilized. Up to 30 patients will be treated weekly on an outpatient basis with the study drug. Patients will be entered in cohorts of three dose tier of rhIL-12 at doses ranging from 3-500 ng/kg administered over the first two weeks of each three week cycle for three cycles. The primary objective is to assess the safety and MTD of rhIL-12 when administered by IP infusion in this patient population.